Bacteria and pathogen characterizations using outer membrane vesicles

PROJECT SUMMARY
There is growing recognition that extracellular vesicles (EVs)–micrometer- or nanometer-sized lipid
particles containing protein and nucleic acid cargoes–are shed by all domains of life. The ubiquity of
prokaryotic EVs suggests that the presence of bacterial EVs in biofluids could be exploited for new
diagnostics/prognostics and even therapies for diverse pathogenic bacteria. There is, however, an unmet need
for methods able to solve a fundamental problem confounding the exploitation of EV information in biology and
medicine--EVs are naturally highly heterogeneous particles and thus those of interest may be present only at
very low abundance in a mixture of other EVs. In this Phase I project, our overall experimental goal is to
address the need for analyzing EV heterogeneity (subpopulations) by focusing on an important class of
bacterial nanoparticles called outer membrane vesicles (OMVs). Specifically, our novel technology platform is
designed to address the problem of resolving OMV subpopulations at the single OMV level by directly
correlating surface protein and nucleic acid cargoes (here small RNAs or sRNAs) of dispersed OMVs, through
highly multiplexed fluorescence imaging analysis coupled with amplified readouts of both cargoes. Our ultimate
goal is to develop a unique imaging platform for the high-content, high-throughput analysis of the protein and
nucleic acid cargoes of single OMVs (and other EVs) obtained from any biological sample. Our platform could
enable novel diagnostic/prognostic “liquid biopsy” tests for bacterial infections by providing a minimally invasive
and more informative alternative (or supplement) to conventional methods, which often rely on lengthy
culturing of target organisms from clinical samples or specimens.
Our innovative platform simultaneously analyzes, in one pass, up to 10 potential OMV biomarkers in as
many as 106 dispersed OMVs obtained from a biofluid such as blood, saliva, or stool. Unlike conventional
methods, our platform can rapidly: 1) analyze diverse EVs; 2) simultaneously read multiple OMV surface
markers and thus detect subpopulations; 3) read single OMV cargoes, greatly raising information yield com-
pared to typical methods producing pooled cargo data; and 4) identify OMV subpopulations based on unique
combinations of biomarkers from points 1-3. We therefore propose three stepwise objectives. First, to optimize
the combined protein/nucleic acid analyses of OMVs shed by representative examples of Gram-negative and
Gram-positive bacteria (E. coli and S.aureus, respectively). Second, to test the capability of our platform for the
analysis in situ of sRNA cargo using dispersed single OMVs representing these major group classifications.
Third, combine our surface molecule and sRNA analysis methods for the correlated direct detection in situ of
both protein and nucleic acid cargoes in dispersed single OMVs representing the two major groups. We
anticipate that our platform could become a new research/diagnostic/prognostic tool for managing pathologies
in which OMV analysis is clinically informative, and for monitoring normal or aberrant microbiome status.

Public health relevance
PROJECT NARRATIVE Natural biological nanoparticles called outer membrane vesicles (OMVs) are involved in bacterial infections, as well as in normal physiology, such as a healthy microbiome. We will develop and test a new technology for detailed OMV analysis that, in the long term, is designed to improve methods for diagnosis and prognosis of infections and other pathologies, and that may ultimately lead to better outcomes and new treatment methods.